Targeting Remyelination to Treat Preterm Brain Injury

Contact P.I.: Ostrem, B.E.L.
PROJECT SUMMARY
Preterm white matter injury (PWMI) is the most common type of brain injury in premature infants and is
associated with adverse neurological outcomes, including cerebral palsy, cognitive and learning disabilities, and
seizures. PWMI is caused by a differentiation arrest in the oligodendrocyte (OL) lineage, and a failure of
myelination. As there are no specific treatments, care is supportive and focused on rehabilitation. However, novel
high-throughput screening methods have enabled the identification of remyelinating, or pro-myelinating,
compounds that promote OL differentiation and myelination. We hypothesize based on overlapping
mechanisms of remyelination and developmental myelination that remyelinating compounds are an
untapped source of potential therapeutics for PWMI. Here, we demonstrate the development of a therapeutic
pipeline for PWMI where remyelinating compounds are identified using a high-throughput in vitro screening
platform, binary indicant for myelination using micropillar arrays (BIMA). Screen hits that meet key criteria
suggestive of safety and feasibility in neonatal neurological applications are validated in vitro and tested in a
murine chronic hypoxia model of PWMI. We further propose to complete a Phase I clinical trial of a promising
remyelinating compound that has completed testing through our preclinical pipeline, clemastine, in neonates with
PWMI. This oral antihistamine is approved in patients ages 3 and older for allergic indications and was recently
shown to promote remyelination in adults with multiple sclerosis. Neonatal safety and pharmacokinetic (PK) data
are needed prior to larger efficacy studies for PWMI. We will perform a Phase I/Ib dose expansion/dose
escalation study to test the safety and PK of clemastine in preterm neonates with PWMI. We have worked closely
with the FDA, expert collaborators, and parent advocates on an adaptive, PK-guided trial design that accounts
for prior pitfalls in clinical trials for newborn brain disorders. We will enroll 20 neonates born at ≤32 weeks
gestation, who have PWMI identified by neuroimaging. Neonates will be treated with clemastine for 14 days
while undergoing close monitoring and blood sampling for PK measurements in the intensive care nursery. Blood
and imaging biomarkers will be obtained at enrollment and 3 months after treatment and neurodevelopmental
outcomes will be followed for 2.5 years on all participants. This trial will inform the dosing for and design of a
randomized, placebo-controlled, Phase II trial of clemastine for PWMI. Overall, our high-throughput drug
discovery platform combined with our neonatal feasibility and prioritization system is a new and promising
approach to therapeutic development for PWMI. Our trial design will serve as a road map for similar future trials
for conditions affecting the newborn brain. The application of remyelinating therapies to neonatal brain
injury is conceptually innovative, and our preliminary data are highly supportive of the potential success
of this approach. This work has the potential to fundamentally change the therapeutic landscape, and approach
to drug development, for a devastating neonatal neurological problem with no current treatments.

Public health relevance
Contact P.I.: Ostrem, B.E.L. PROJECT NARRATIVE We propose to target remyelination to promote repair and recovery in preterm white matter injury (PWMI), a significant cause of neurodevelopmental disability in premature babies with no current treatments. We demonstrate the development of a therapeutic pipeline in which remyelinating compounds are identified using high-throughput screening, followed by in vitro and in vivo validation and testing and implementation of well- designed clinical trials in neonates. We believe that the investigator’s extensive background in glial biology, neonatal neurology, and white matter disorders, places her in a unique position to spearhead an innovative approach for the development of therapeutics targeting remyelination for PWMI.